Regulating the glioma immune microenvironment

PROJECT SUMMARY/ABSTRACT
Glioblastoma (GBM) is the most common and the most lethal primary malignant brain tumor. Immuno-
therapeutic strategies to promote an effective antitumor immune response hold great promise for GBM. Yet,
significant barriers remain as the factors that regulate the glioma-associated immune response, including the
microglia, macrophages, and T cells, are poorly defined. While GBM is broadly characterized by a lymphocyte-
depleted, immunosuppressive phenotype, there is a growing appreciation for the diversity of glioma immune
microenvironments. Data from our laboratory and others have identified RAF-driven glioma subtypes with
distinct immune-enriched phenotypes, including increased CD8 T cells, microglia, and macrophages. By
comparing immune-enriched and lymphocyte-depleted glioma subtypes, we have identified a novel role for the
chemokine CXCL14 in promoting a tumor-specific effector CD8 T cell response. Secreted by tumor cells,
CXCL14 promotes both T cell and macrophage chemotaxis. In this proposal, we investigate CXCL14 function
in glioma and directly test its potential to counteract the immunosuppressive microenvironment of GBM. To do
this we leverage our extensive collection of molecularly annotated human brain tumor samples, state-of-the-art
technologies, and murine models for GBM that mimic the characteristic lymphocyte-depleted tumor
microenvironment of human GBM.

Public health relevance
POJECT NARRATIVE Glioblastoma (GBM) is the most common and the most lethal primary malignant brain tumor. Immunotherapeutic strategies represent promising new therapeutic tools as they seek to promote an effective antitumor immune response against a patient’s own tumor. In this proposal, we take advantage of the relatively immune-rich microenvironment of RAF-driven glioma to investigate novel determinants of the glioma-associated immune response, including microglia, macrophages, and T cells.